From the Scanner to the Clinic: Patient Oriented Research and Mentorship

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The overall goal of this application is to allow the investigator (Diana Martinez, MD) to engage in new directions in research while providing mentorship to trainees pursuing careers in substance use disorders (SUD) research. The new directions in research include interventional psychiatry for SUD, as follows: 1) a clinical trial of transcranial magnetic stimulation (TMS) for cocaine use disorder; 2) a human laboratory self-administration trial of alcohol use disorder using TMS; and 3) an investigation of ketamine combined with mindfulness (delivered via a free mobile phone app) to address smoking cessation. The advantage of these types of procedures is that they could be
implemented in a clinical setting should they have clinical efficacy. These new directions in research are combined with mentorship. Dr. Martinez is now the co-director of our institution’s T32 program (Translational Clinical Research Fellowship on Substance Use Disorders). In this capacity, Dr. Martinez is involved overseeing the daily management of the program. These responsibilities include matching fellows with mentors; assisting fellows with protocol submissions; reviewing and revising applications for pilot awards; reviewing and critiquing fellows’ grant submissions and ensuring that fellows meet milestones. Dr. Martinez is director of our T32’s Early Action pipeline program, which serves to increase interest among medical students in research careers dedicated to developing treatments for SUD.

Public health relevance
This K24 Midcareer Investigator Award in Patient-Oriented Research will enable Dr. Diana Martinez to advance her skills in clinical research and provide mentorship to clinical researchers, including fellows in addiction psychiatry and medical students. This K24 proposes a focused interdisciplinary program for Dr. Martinez and a comprehensive plan for mentoring clinician investigators.